Integrated Health Sciences Facility Core

ABSTRACT INTEGRATED HEALTH SCIENCES FACILITY CORE The specific objectives of the Integrated Health Sciences Facility Core (IHSFC) are to: 1) Provide the services, instrumentation and technologies needed for basic and applied environmental health research, including population-scale genomics, cell and molecular analytics, and environmental exposures and chemistry; 2) Support translational research to improve exposure characterization, early detection of disease risk, biomarker discovery and development of preventive interventions for environmentally related diseases; 3) Provide training in methods and technologies to present and future environmental health scientists. To achieve these goals, the IHSFC consists of the Bioanalysis, Environmental Genomics, Particles, Metals, and Organics Services. Each service provides: 1) scientific expertise and advice to Center investigators on how to best accomplish their goals; 2) in-house instrumentation, exposure chambers, and technical staff for biological and environmental studies; 3) access to an extraordinary menu of other analytical services in the Harvard Medical area, the Harvard-Cambridge campus, and beyond. The IHSFC supports the translational mission of the Center by the analyses performed, by maximizing efficient use of small samples from subjects in population studies, and by assisting investigators in communicating results to community groups and policymakers. Each IHSFC service also trains students, post-docs and other environmental scientists in the technologies offered. The overall benefit to the NIEHS Center is expertise and provision of analyses, assistance with translation of research and the training and development of future environmental health scientists.

Public health relevance
INTEGRATED HEALTH SCIENCES FACILITY CORE NARRATIVE The Integrated Health Sciences Facility Core (IHSFC) provides access to the services, instrumentation and technologies needed for basic and applied environmental health research, including population-scale genomics, cell and molecular analytics, and environmental exposures and chemistry. The IHSFC supports the translational mission of the Center directly by the analyses performed, and also indirectly by maximizing efficient use of small samples from human subjects in population studies, making it easier for the subjects and thereby making it easier to conduct the studies of human environmental health effects. Each IHSFC service also trains students, post-docs and other environmental scientists in the technologies offered, and helps provide materials for the communication of results to community groups and policy makers.